USC/UCLA Center for Biodemography and Population Health: Core A

Abstract – Core A
The Administrative and Research Support Core (ARC) is responsible for initiating and coordinating all activities
undertaken by the USC/UCLA Center on Biodemography and Population Health (CBPH). The overarching aim
of the Center is to promote scientifically important research and to develop infrastructure and resources
designed to foster and support innovation and progress in methodological and substantive issues that will most
effectively promote significant scientific advancement in the area of Biodemography. To accomplish our goal,
we leverage the unique and complementary expertise of the CBPH co-directors and their respective
institutions, combining expertise and experience in classic demographic analysis and methods, genetics and
genomic theory and methods, and clinic- and community-based, epidemiological/biological research methods.
The aims of the ARC are to (1) provide national and international leadership in the field of Biodemography by
arranging seminars and meetings that provide discussion of theory, methods, and analytic approaches for
using biological data from large populations; (2) develop networks of appropriate experts from around the world
who can provide information on theory, methods, and data relevant to novel biomarkers in populations; (3)
encourage the hiring and development of faculty affiliates at USC and UCLA who can further the research aims
of the CBPH; (4) perform the administrative and financial tasks required for the management and direction of
the CBPH; (5) provide oversight and support for activities of the Program Development Core [PDC] ; and (6)
provide oversight, support and scientific leadership for activities of the Research Development and Research
Resources and Dissemination Core [RRDC]. Our past efforts have generated methodological and substantive
knowledge of great value to population health researchers generally, and have promoted growth of the field of
biodemography by encouraging improvements in methods relating to collection and analysis of biological data
and substantive understanding of biological parameters. The effective administration of the CPBH has been
largely responsible for accomplishing Center aims. We propose to maintain these effective organizational
structures and functions of the ARC from the past period in order to continue to provide the biodemographic
infrastructure needed to support significant improved and expansion of scientific progress in addressing major
substantive questions in the field of biodemography.